Deciphering the role of a novel micropeptide in cardiac function and dysfunction

Project Summary/Abstract
Ca2+ controls cardiac function by acting as the primary regulator of the sarcomeric contractile machinery and as
a second messenger in the signal transduction pathways that control cardiac growth, metabolism and
pathological remodeling. Ca2+ handling in striated muscle is tightly regulated by Ca2+ pumps in the sarcoplasmic
reticulum (SR) and plasma membranes that maintain intracellular Ca2+ levels ~10,000-fold lower than
extracellular and SR concentrations. Ca2+ release from the SR membrane transiently increases Ca2+ levels in
the cytosol, triggering actomyosin cross-bridge formation within the sarcomere to generate contractile force.
Reuptake of Ca2+ into the SR by sarcoplasmic reticulum Ca2+-ATPase (SERCA) is necessary for muscle
relaxation and restores SR Ca2+ levels for subsequent contraction-relaxation cycles. SERCA thus serves as a
central regulator of cardiac function, as well as the pathogenic signaling cascades that drive heart disease. The
activity of SERCA in the heart is modulated by phospholamban (PLN), a tiny peptide that interacts with SERCA
in the SR membrane and diminishes Ca2+ pump activity. We discovered that a cardiac-specific RNA annotated
as a long noncoding RNA actually encodes a previously unrecognized micropeptide, which we named DWORF
(Dwarf Open Reading Frame). During the initial funding period we showed that DWORF has a higher binding
affinity for SERCA than PLN and that DWORF overexpression mitigates the contractile dysfunction associated
with PLN overexpression, substantiating its role as a potent activator of SERCA. Additionally, using a mouse
model of dilated cardiomyopathy, we showed that DWORF overexpression restores cardiac function and
prevents the pathological remodeling and Ca2+ dysregulation. Our results established DWORF as a potent
activator of SERCA within the heart and as an attractive candidate for a heart failure therapeutic. Recently, we
discovered two PLN-related micropeptides, referred to as Endoregulin (ELN) and Another-regulin (ALN), which
associate with specific SERCA isoforms, suggesting their involvement in SERCA-dependent Ca2+ signaling.
Collectively, we refer to this family of inhibitory SERCA micropeptides as Regulins. Our discovery of the DWORF-
Regulin micropeptides provides new inroads into our understanding of the mechanisms involved in cardiac
contractility and function and points to unexplored roles of micropeptides in the control of cardiovascular
physiology and pathology. Our hypothesis is that DWORF-Regulin micropeptides are critical for cellular
homeostasis and stress adaptation in disease, such that these micropeptides can serve as therapeutic targets
for cardiovascular and metabolic diseases. The overall goals of this proposal are to define the functions and
regulatory protein-protein interactions of DWORF and Regulins in the cardiovascular system and evaluate their
therapeutic significance.

Public health relevance
Project Narrative The proposed research is relevant to public health because understanding the regulatory roles of the micropeptides discovered in our lab to have key roles in development, function and disease of muscle cells, provides new insights in fundamental cellular processes and provides opportunities for therapeutic manipulation of cardiovascular and metabolic disease. Thus, this proposal is relevant to the part of NIH’s mission that pertains to fostering fundamental creative discoveries and innovative research strategies as a basis for ultimately protecting health.